FAIR DOs: Findable, Accessible, Interoperable, Reusable Development of Open Simulation

PROJECT SUMMARY
FAIR DOs (Findable, Accessible, Interoperable, Reusable: Development Of Simulations) is a 5-year research
education program in the modeling and simulation of digestive and renal neurobiology. It is developed by a team
of award-winning faculty of educators and researchers who, among other things, is behind the FAIR mapping
and knowledge management infrastructure for the SPARC effort. The main thrust of FAIR DOs is to educate the
next generation of researchers and clinicians in the neural regulation of digestive and renal epithelia through
taught modules and supervised modeling projects that make use of SPARC datasets, maps, and models. The
FAIR DOs faculty will leverage teaching structures at Case Western Reserve University to recruit students.
Overall, FAIR DOs aims to provide about 35/45 hours of training to over 75 students over the proposed five-year
project, with each student research project producing one publication in the Physiome journal--launched by the
International Union of Physiological Sciences. The SPARC Portal will provide findability to these student-
generated open-access models and associated data via its Search and Flatmaps functions, as well as accessible
interactivity via the O2S2PARC simulation platform. Overall, the FAIR DOs effort will provide a unique
educational, mentored experience that will also generate a SPARC ecosystem of interoperating models that
coherently study the neurobiology of digestive and renal epithelial transport. From a didactic “Systems”
perspective, this ecosystem of models will be organized to follow the teaching narrative of the British Medical
Association Award-winning “Medical Physiology 3rd Ed.” textbook, supplemented with recent literature, setting
the stage to further leverage SPARC resources for education in the future.

Public health relevance
PROJECT NARRATIVE The gastrointestinal tract and kidneys provide respectively about 200 and 350 square meters of body surfaces to the outside world - by far the largest surfaces in the body. The FAIR DOs program will educate the next generation of researchers in using the latest computational tools to study transport processes across these crucial surfaces. The use of FAIR methods will also ensure that students appreciate the importance of open science, data sharing, standardization and large-scale collaborative modeling efforts.